Wadsworth Center's Human Health and Exposure Analysis Resource (WC-HHEAR)

PROJECT SUMMARY / ABSTRACT
The overall objective of this supplement proposal is to provide the Wadsworth Center’s Human Health and
Exposure Analysis Resource (WC-HHEAR) the resources to support unanticipated additional work associated
with the Chronic Kidney Disease of UnceRtain Etiology (CKDu) in Agricultural Communities (CURE) Research
Consortium. WC-HHEAR provides CURE with access to state-of-the-art analyses for exploring the effects of
environmental contaminants on chronic kidney disease. WC-HHEAR’s extensive infrastructure, expertise, and
reputation as a world-class trace elements laboratory located within the NY State Department of Health’s
Wadsworth Center is widely recognized. Within the Center’s Division of Environmental Health Sciences (DEHS),
biospecimens are analyzed for toxic metals within the Trace Elements Lab (TREL). Dr. Patrick Parsons is the
Director of DEHS and is the Principal Investigator for the TREL. Dr. Parsons has more than 40 years of
experience in analytical chemistry applied to measuring trace elements in human tissues and body fluids. The
TREL group analyzes biospecimens for up to 41 trace elements that include toxic (lead, cadmium, mercury, and
arsenic) and essential (copper, selenium, zinc) elements in whole blood, urine, and serum/plasma, plus the 16
rare earth elements, which includes the lanthanides series. The TREL has extensive expertise analyzing non-
traditional matrices such as placenta, cord blood, baby teeth, dried blood spots, hair, nails, amniotic fluid, breast
milk, saliva, and other tissues. This supplement leverages Wadsworth’s capacity and capability to provide high
complexity laboratory analyses to support the additional needs of the CURE consortium. Specifically, WC-
HHEAR has the capability and capacity to analyze an additional 600 blood specimens for 24 trace elements
and an additional 600 urine specimens for 24 trace elements using well validated clinical methods based on
tandem inductively coupled plasma mass spectrometry (ICP-MS/MS). Since WC-HHEAR is a CLIA-certified
laboratory, some of these test results may be reported back to study subjects. In addition to analyzing 600 urine
specimens for a suite of trace elements, WC-HHEAR has the capability and capacity to analyze 300 urine
specimens for 5 arsenic species using a well validated method based on Liquid Chromatography coupled to
ICP-MS/MS.

Public health relevance
PROJECT NARRATIVE The Wadsworth Center’s Human Health and Exposure Analysis Resource (WC-HHEAR) will capitalize on Wadsworth’s strengths and extensive capabilities as the New York State Department of Health’s world class public health laboratory and research institute to provide support for the Chronic Kidney Disease of UnceRtain Etiology (CKDu) in Agricultural Communities (CURE) Research Consortium. Wadsworth Center is an established Human Health Exposure Analysis Resource (HHEAR) laboratory hub specializing in the targeted analysis of human specimens for a broad range of environmental contaminants. Wadsworth’s analytical expertise analyzing human biospecimens for toxic metals is critical to the success of CURE.